Immune regulation to Coccidioides infection

PROJECT SUMMARY
Coccidioidomycosis, or Valley fever, is caused by inhalation of the fungus Coccidioides. The health impacts
of Valley fever infection vary dramatically, and little is known about the biological factors that influence the
severity of symptoms and health complications experienced following infection. Valley fever diagnosis,
treatment and vaccine development have been hampered by a lack of basic immune knowledge about the host
response to Coccidioides. Published data from our group determined that the inability of patients to resolve
Coccidioides infection may be a result of elevated regulatory T cell frequency and functional capacity, and that
regulatory T cell frequency may predict patient disease outcome at diagnosis. This proposal seeks to define the
mechanistic role of regulatory T cells in controlling responses to Coccidioides infection and the influence of
inhibitory receptors in immune fungal control. The overall goal of this research study is to provide fundamental
knowledge about immune responses to Valley fever, filling gaps in knowledge, as a foundation to improve
diagnosis, treatment and vaccine development for a rapidly expanding fungal disease. To achieve this goal, we
will define the mechanisms of T cell regulation, kinetics and localization during infection, and manipulate
regulatory and effector T cells using immune modulating antibodies in mouse infection models. Although the
details are still unclear, cellular immune responses have long been shown to be critical for effective immunity
to Coccidioides infection. In some patients, Valley fever results in a severe or prolonged clinical illness with
dramatic health impacts, including chronic pulmonary nodules and dissemination outside the lungs. This
proposal will evaluate how immune regulation modulates fungal clearance during Coccidioides infection.

Public health relevance
PROJECT NARRATIVE Coccidioidomycosis, or Valley fever, is caused by inhalation of the fungus Coccidioides endemic to the San Joaquin Valley in California and the Southwestern United States. Incidence is on the rise, and the health impacts of Valley fever infection can range from superficial to lethal, resulting in significantly impaired health for long periods. This research study provides fundamental knowledge about immune responses to Valley fever, as a foundation to diagnosis and treatment for a rapidly expanding fungal disease with disparities in health care.